SEPSIS SCREEN IN INFANTS WITH NOSCOMIAL INFECTIONS

This study has examined the usefulness of the sepsis screen for the early detection of infected infants. Study enrollment is complete and data analysis is underway.